Defining successful intrahepatic CD4+ T cell responses against the hepatitis C virus

Approximately 180 million people globally, including 2-3 million in the United States, live with chronic hepatitis C
virus infection. Persistent HCV replication causes progressive liver injury including cirrhosis and cancer. Direct
acting antivirals (DAA) that cure chronic HCV infection have been available for a decade but new infections
outpace treatment. New cases of HCV infection doubled between 2013 and 2022 and it is unlikely that treatment
alone will interrupt virus transmission. A vaccine to prevent chronic HCV infection could provide a cost-effective
solution to this problem and is supported by substantial evidence. Spontaneous resolution of infection in 25-30%
of humans and chimpanzees provides life-long immunity that sharply reduces the risk of persistent infection with
diverse HCV genotypes. Vaccine-mediated protection will likely require broadly neutralizing antibodies and a T
cell response that is sustained until after apparent clearance of the virus. The objective of this proposal is to
define the protective CD4+ T cell signature that supports effective CD8+ T cell immunity. Human CD4+ T cells are
challenging to study. CD4+ T cells target multiple class II epitopes and circulate at low frequency. They are
therefore difficult to visualize and enrich with class II tetramers. Blood sampling is typically infrequent in
prospective studies of those at risk of infection and liver is rarely sampled during acute hepatitis C.
Here, protective T cell immunity will be defined with historical blood and liver samples collected from
chimpanzees between 2005 and 2013 with NIH approval and funding. Preliminary studies support this approach.
Co-expression of the PD-1 and ICOS activation antigens was established as surrogate marker for direct ex vivo
visualization and enrichment of HCV-specific CD4+ T cells, a significant advance for feasibility of the proposed
studies. The blood response coincided with peak ALT and infiltration of multifunctional HCV-specific CD4+ T cells
into liver. HCV-specific CD4+ T cell responses will be defined by single cell RNA sequencing (scRNAseq) and
spatial genomic analysis of liver, technologies that did not exist when the samples were collected. An innovative
Central Hypothesis was developed from preliminary scRNAseq studies: CD4+ T cells infiltrate liver to form
lymphoid aggregates, where they attract and regulate intrahepatic CD8+ T cell responses to HCV. Lymphoid
aggregates were first defined in liver during the non-A,non-B hepatitis era. Their function and significance in
acute hepatitis C remains unexplained. Here, we propose that they are a site for close range CD4+:CD8+ T cell
communication that determines infection outcome. This hypothesis is supported by identification of a unique
HCV-specific CD4+ T cell population that differentially expressed CXCL13 and LGALS9, which encodes the
galectin-9 inhibitory ligand implicated in CD8+ T cell exhaustion. These CD4+ T cells had a transcriptional profile
consistent with formation of tertiary lymphoid structures. Transcriptional and spatial characterization of HCV-
specific CD4+ T cells in blood and liver, facilitated by identification of a key surrogate marker of the response, is
expected to fill a substantial gap in knowledge critical for understanding HCV control and vaccination of humans.

Public health relevance
Approximately 180 million people globally, including 2-3 million in the United States, live with chronic hepatitis C virus infection. HCV transmission has increased sharply over the past decade despite new therapies that cure the infection. The objective of this proposal is to define protective immune responses against HCV for development of a vaccine that prevents chronic infection and the serious liver diseases including cancer that it causes.